Integrated Research Facility at Fort Detrick

For FY15, the Integrated Research Facility in the Division of Clinical Research has significantly increased the level of research facilitation that it provides. Primarily, this support has been directed to facilitating the biodefense and emerging infectious disease research of the Emerging Viral Pathogens section in the Division of Intramural Research, reported separately. In addition, core capabilities of the IRF have been established to include clinical pathology, anatomic pathology, electron microscopy, confocal microscopy, immunology, and cell culture.